Comprehensive Patient-centered Home-based care coaching for COPD self-management

Chronic obstructive pulmonary disease (COPD) affects 10-15% of U.S. adults, costs over $37 billion annually,
and causes serious symptoms, physical impairment and high hospital admission and mortality rates. Much of its
burden can be reduced by following guideline recommended self-care activities, like daily use of disease
controlling medications and pulmonary rehabilitation. Yet patients often struggle with the self-care needed to
maintain or improve their health. The potential barriers to successful self-care are numerous, encompassing
socioeconomic, psychosocial, physical, cognitive and other domains. Moreover, many of the barriers are major
contributors to health inequities, as reflected in poorer access to COPD treatments and poorer outcomes among
racial and ethnic minority patients. Most COPD self-management support interventions have largely followed
one-size-fits-all strategies of education and training. We created the Supporting self-Management Behaviors for
aging Adults (SaMBA)-COPD intervention based on the successful SaMBA program for older adults with asthma.
The model is unique among chronic illness self-management programs because it involves comprehensive
screening for barriers to self-management and disease control and couples it with tailored, theory-based, barrier-
specific interventions. The intervention is delivered by community health workers and includes steroid and
antibiotic prescribing for early intervention of COPD exacerbations and home-based pulmonary rehabilitation
(HBPR). Our feasibility trial of SaMBA-COPD, conducted with a predominantly Black and Latinx population, met
most of the benchmarks for success, including complete preparation of all intervention and study related
materials and protocols, intervention fidelity and patient acceptability, and outcomes that suggest the intervention
will improve self-management behaviors and reduce COPD symptoms. We now propose a fully powered
randomized trial among inner-city adults with COPD (n=300). The Specific Aims are to test the impact of SaMBA-
COPD on (1) COPD controller medication adherence and other self-management behaviors at 6 months; (2) on
clinical outcomes (COPD symptoms measured with the COPD Assessment Test and 6-minute walk test
distance) at 6 months, and emergency department visits and hospitalizations at 12 months; and (3) to examine
mechanisms of intervention effect on medication adherence and clinical outcomes, with a focus on the role of
COPD illness and medication beliefs. We will recruit adults ages 40 years and older with advanced COPD in
outpatient practices in New York City. The intervention will be delivered for 6 months. Attention control patients
will receive untailored COPD education. Sustainability of treatment effects will be evaluated at 12 months. The
intervention is significant and innovative for its comprehensive pre-trial preparation, attention to the full range of
contributors to suboptimal self-management and COPD control, the broadening of community health workers'
scope of practice to include HBPR, and the project's focus on achieving equity in healthcare and health outcomes
for Black and Latinx COPD patients.

Public health relevance
We propose a randomized controlled trial of a self-management support intervention for low-income, minority adults with COPD that involves comprehensive screening for and targeted management of barriers to COPD control and combines this with home-based pulmonary rehabilitation and pre-emptive medication prescribing for COPD exacerbations. We will compare the intervention with an attention control for effects on COPD controller medication adherence and other self-management behaviors, symptoms and exercise capacity at 6 months and hospitalizations and emergency department visits at 12 months.